Disseminate data on cognitive functioning to investigate long run effects of exposure to natural disasters

Summary/Abstract
Natural disasters are increasing in frequency and intensity across the globe. Understanding the consequences
of exposures to trauma associated with disasters for health and human development is limited by the dearth of
data on well-being after such exposures. This project addresses the gap by disseminating innovative data on
cognitive performance for a population-representative sample of children and adults, some of whom were
directly exposed to the 2004 Indian Ocean Tsunami whereas others were not. Domain-specific cognitive skills
that have a foundation in neuroscience were assessed using touch-screen tablets in an experimental pilot
study conducted 13 years after the tsunami. Having established the validity and value for scientific research of
these pilot data, our first aim is to place data on cognitive function in the public domain. To facilitate
research by population scientists, we will construct measures that are used in the cognitive neuroscience
literature and also provide the underlying raw data. Our second aim is to provide high quality
documentation explaining the measures and their interpretation. This includes thorough descriptions of
the tasks, how they are played, the construction and meaning of the measures we provide, and how they are
interpreted in the cognitive neuroscience literature. Providing well-documented data in a ready-to-use format
will minimize start-up costs for scientific research by investigators across multiple disciplines.
The cognitive data provided by this project will include anonymized identifiers that enable household- and
individual-specific linkage to the Study of the Tsunami Aftermath and Recovery (STAR), an on-going
longitudinal individual and household survey conducted in Aceh, Indonesia. The STAR baseline, conducted 10
months before the 2004 Indian Ocean Tsunami, is representative of the population living in coastal districts of
Aceh, the area that was hit hardest by the tsunami. STAR is representative of tsunami survivors: we have
completed 7 follow-ups, maintained extremely high follow-up rates, and interviewed over 98% of all baseline
survivors at least once post-tsunami. The cognitive pilot covered a 25% random subsample of STAR
respondents: assessments were completed by over 91% of the target respondents (baseline survivors and
their children born after the tsunami). Linkage to STAR data by investigators will provide a plethora of detailed
information on community and individual exposure to the tsunami, as well as respondent and household
demographics, health, migration, work, schooling, marriage, fertility, and resource availability including income,
expenditure, and wealth. Pilot data and documentation placed in the public domain by this project will
substantially enrich the existing data infrastructure for scientific research on cognitive performance of adults
and children in low resource settings and in the context of large-scale disasters.

Public health relevance
Project Narrative This project will place in the public doman unparalleled data on the cognitive functioning of a population exposed to a major natural disaster. The data provide scientists with unique detailed information on key dimensions of cognition that have a foundation in neuroscience for a large population-representative sample of adults and children, some of whom were directly exposed to the 2004 Indian Ocean Tsunami, in Aceh, Indonesia. Investigators using these data stand- alone, and also merged with publicly-available longitudinal survey data from the Study of the Tsunami Aftermath and Recovery (STAR), will advance scientific understanding of demographic and socioeconomic factors linked to cognitive functioning.